Development of synthetic heparin to protect liver graft from ischemia reperfusion injury during transplantation

Project Summary/Abstract
This STTR phase II application is to seek continuation support to develop a carbohydrate-based
reagent, dekaparin, to protect from liver damage during the organ recovery and preservation
process. Liver transplant is an effective treatment option for hepatocellular carcinoma and end
stage liver disease patients. However, the transplant process unavoidably involves ischemia-
reperfusion (IR) injury. IR injury leads to adverse outcomes in recipients including primary non-
function of the graft, biliary complications, acute cellular rejection and tumor recurrence.
Furthermore, due to the high demand of limited available organs, extended criteria donor (ECD)
livers, which are more susceptible to IR injury, are often allocated to liver tumor patients who have
preserved liver function. Retrospective studies have found that over 20% of recipients receiving
ECD grafts have tumor recurrence within 3 years post-transplant. Currently, there are no
preservation solutions equipped to decrease IR injury beyond what is experienced by ideal donors
after a short cold storage time. Therefore, targeting IR injury to prevent adverse post-transplant
outcomes is of urgent importance. Considering the multiple mechanisms of action of dekaparin,
we expect that adding dekaparin to preservation solutions will reduce IR injury in the recipient,
translating to a reduction in early allograft dysfunction, improved graft survival and fewer re-
transplants needed. The overall goal of this work is to increase the utilization of ECD livers by
reducing the IR injury burden that is often associated with ECD use. In this way, more recipients
can receive a life-saving liver transplant.
In the Phase I project period, dekaparin was used in an ex vivo model of liver perfusion and
demonstrated efficacy in reducing liver injury after cardiac arrest and cold ischemia. Additionally,
during the Phase I project period, our team participated in NIH National I-CORPS to validate our
beachhead market as an additive in organ preservation solution. In this Phase II proposal, four
specific aims are proposed to complete preclinical studies and prepare for a pre-submission
meeting request by the end of the project period. The specific aims include 1) evaluating
dekaparin’s effect against IR injury in a deceased donor porcine liver transplantation model; 2)
evaluating dekaparin’s effect on tumor recurrence after deceased donor rat liver transplantation;
3) dekaparin use in an ex vivo human discarded liver model with machine perfusion; and 4)
determination of dekaparin concentration in biological samples from Aims 1-3. We intend to apply
for a STTR Phase IIb award with matching funding from a strategic partner to complete an early
feasibility, first in human study.

Public health relevance
Project Narrative For some liver cancer patients, a liver transplantation represents a cure, yet this procedure involves ischemia reperfusion injury which effects graft function and leads to tumor recurrence. Glyco Discoveries in collaboration with the University of North Carolina Chapel Hill and Duke University, will investigate the use of dekaparin to reduce transplant associated ischemia reperfusion injury. The success of this project will offer a way to mitigate a common complication which has no existing therapeutics available.